A dual function TB subunit vaccine designed for non-interference with BCG and post-exposure activity

ABSTRACT
Despite widespread use, the only licensed tuberculosis (TB) vaccine available for human use, M. bovis Bacille
Calmette-Guerin (BCG), has not been able to prevent TB from becoming a global health emergency. To achieve
the 2030 targets of the WHO End TB Program, a new TB vaccine strategy is needed. For optimal effect, such a
strategy will need to offer both improved efficacy following vaccination of TB-naïve infants, as well as vaccine
efficacy in the population of M. tuberculosis (Mtb)-exposed adolescents/adults in endemic regions. Advances in
our understanding of TB immunology and vaccinology allow for a more tailored vaccine designed for this dual
function. Based on specific antigen selection and adjuvanted administration, we have developed a novel single
vaccine with dual use as a co-vaccine alongside BCG for naïve individuals and as a standalone vaccine for
previously exposed/infected individuals. This designed hybrid protein subunit vaccine (ESX1-Vax) is composed
specifically of secreted ESX-1 related antigens that are missing from BCG, including ESAT-6 whose targeting is
uniquely protective against re-growth of pre-existing infection. The hybrid protein is delivered with the CAF01
adjuvant that is highly effective in promoting T cell responses with defined TB-protective phenotype and function.
Co-administration of ESX1-Vax/CAF01 with BCG does not hinder BCG effects. Instead, it acts synergistically to
complement BCG vaccination by priming differentiation-resistant T cells targeting ESX-1 virulence factor
antigens. As a non-replicative subunit vaccine, ESX1-Vax is also readily boostable. Furthermore, administration
of ESX1-Vax/CAF01 in a post-exposure setting is highly efficacious against bacterial re-growth. In this proposal,
we aim to optimize the immunogencity and efficacy of this ESX1-Vax through molecular modifications to
maximize the T cell response against ESAT-6 epitopes. We will compare the modified constructs for efficacy
and immunogenicity after BCG co-vaccination and in standard and newly-established post-exposure vaccination
models to select the optimal ESX1-Vax construct. The selected construct will then be developed for production
as a final GMP-produced ESX1/CAF01 product, verified for vaccine activity and assessed for toxicology. The
overall outcome of this product development is, thus, a single boostable vaccine that is uniquely designed to
work both together with BCG prophylactically in non-infected neonates, as well as when delivered post Mtb
exposure in latently infected individuals, and that is ready for progress to clinical trials.

Public health relevance
PROJECT NARRATIVE We have developed a tuberculosis (TB) vaccine with dual function as a co-vaccine alongside BCG for naïve individuals and as a standalone vaccine for previously exposed/infected individuals. Inspired by recent advances in TB immunology, we aim to further optimize and develop this vaccine using molecular modifications and testing in advanced animal models. Our final optimized product will be GMP produced and documented for progression towards clinical trials.